Reducing Perioperative Oxidative Stress to Prevent Postoperative Chronic Pain Following Total Knee Arthroplasty

Abstract
Approximately 1 million total knee arthroplasty (TKA) procedures are carried out in the U.S. annually to
address pathology underlying knee joint pain and functional limitations resulting from osteoarthritis. TKAs are
conducted primarily in older adults, and while effective for pain reduction in many, 15% or more of TKA
patients report unsatisfactory long-term pain outcomes despite a technically successful surgery. Post-TKA pain
at up to 4-year follow-up has been reported to be worse than the preoperative pain in 7% of TKA patients.
While mechanisms contributing to long-term pain post-TKA are not well-understood, our prior longitudinal
project (R01AG048915) found evidence that oxidative stress (OS) may be one contributor to post-TKA chronic
pain. Elevated intraoperative pre-incision levels of F2-isoprostanes and isofurans (the most sensitive in vivo
OS biomarkers) and increased expression of these biomarkers during tourniquet application in standard TKA
procedures predicted greater post-TKA pain intensity (past 24 hour and past week) at 6-months post-TKA. The
proposed project builds on this prior work and will answer a critical clinical question: does reducing OS in the
preoperative and perioperative period improve long-term post-TKA pain outcomes? We propose a prospective
randomized placebo-controlled trial that will examine preoperative, perioperative, and long-term OS; pain; and
functional outcomes and test for the first time the hypothesis that a potent antioxidant intervention (Glycine plus
N-acetylcysteine [GlyNAC]) reduces OS and chronic postsurgical pain in patients undergoing TKA. GlyNAC
has been shown to dramatically decrease F2-isoprostanes in initial trials, supporting its potential utility as an
antioxidant intervention for improving post-TKA pain outcomes. Given the large number of older adults
experiencing adverse post-TKA chronic pain outcomes each year (≈150,000 annually), the proposed project
could potentially have practice-changing clinical implications. We will enroll older adult osteoarthritis patients
undergoing primary unilateral TKA and randomize them to receive GlyNAC (n=74) or placebo (alanine; n = 74)
beginning 4 weeks prior to TKA with continuation until 6 weeks post-TKA. Baseline pain and psychosocial
phenotyping will be carried out and OS will be assessed in the patient’s home at 4 weeks pre-TKA (T0) and
again after 4 weeks of the intervention [3 days prior to TKA] (T1); perioperatively at pre-incision [T2], 45
minutes after tourniquet application [T3], and 15 minutes post-tourniquet removal [T4]; and at post-TKA follow-
ups. Pain, function, and opioid use outcomes will be assessed at 6-week, 6-month, and 12-month follow-up.
We will test the hypothesis that GlyNAC reduces OS and pain intensity, improves function, and reduces opioid
analgesic use at 6-week and 6-month (primary) follow-up compared to placebo. We will also test whether
GlyNAC-related reductions in pain intensity at 6-month follow-up are maintained at 12-month follow-up, and
whether pre-GlyNAC baseline OS levels moderate efficacy of GlyNAC for improving long-term pain outcomes.

Public health relevance
Project Narrative Approximately 1 million total knee arthroplasty procedures are performed in older adults each year, but 15% or more of patients report unsatisfactory long-term pain outcomes despite a technically-successful procedure. Although mechanisms contributing to chronic post-TKA pain are poorly understood, our recent prospective work suggests that elevated oxidative stress may contribute. This project will use a randomized, placebo-controlled design to test for the first time whether a potent antioxidant intervention (glycine + N- acetylcysteine) improves long-term post-TKA pain, functional, and opioid use outcomes.